Methods and Health Informatics Core

PROJECT SUMMARY: Methods and Health Informatics Core
The overall goal of our BIGDATA Methods and Health Informatics (MHI) Core is to support rigorous and
efficient research especially related to type 3 and type 4 translation research with a sub-theme of health equity.
Our CCCR's selection of the sub-theme of health equity and community engagement was motivated by the
heightened awareness that historically marginalized populations are disproportionately affected by chronic
conditions including rheumatic and musculoskeletal diseases (RMDs), especially in the Deep South. We
recognize that translating research into clinical care and community settings is key for improving outcomes of
patients with RMDs. We propose to achieve this by offering services in pragmatic study design including
optimization trial designs, data capture that is simpler, faster, and less costly, and state-of-the-art data
analysis. Our proposed MHI Core has gathered a diverse team with expertise in biostatistics, clinical
informatics, machine learning including natural language processing, epidemiology, software
development, and implementation science. Our expertise in offering optimization trial designs within the
Multiphase Optimization Strategy such as Sequential Multiple Assignment Randomized Trials will facilitate
development of patient-centered scalable and sustainable interventions that can support the goal of health
equity. We have amassed a breath of software tools to support data capture in different settings and data
resources to embed research into routine care as well as to scale infrastructure nationally to foster real-world
evidence generation. To this end, the MHI Core will support the new Dissemination, Implementation for
Community Engagement (DICE) Resource Core with tools that enhance recruitment of underserved
populations (focused on a diverse array of study types) and support pragmatic effectiveness and
implementation science studies. MHI Core's focus is to advance the NIAMS research mission and the ongoing/
future investigations of the BIGDATA user base via the following specific aims: 1) To support the selection
and implementation of study designs for BIGDATA investigators pursuing NIAMS-related research
(Study Design); 2) To expand the range of data sources available to RMD researchers and provide
electronic data capture support for their studies (Data Capture and Data Engineering); and 3) To
provide data analysis consultation and support for studies related to NIAMS-related research (Data
Analysis). We are uniquely prepared and strongly committed to scientific rigor, innovation, and development of
new knowledge and translational techniques clinically relevant to the NIAMS mission. Our strengths in study
design and rigorous state-of-the-art analysis coupled with the data capture and data engineering software, and
data resources we already support will enable our investigator base to foster knowledge that is generalizable
and helps the goal of health equity.